The Bring BPaL2Me Trial - Comparing Nurse-Led RR-TB Treatment in Primary Care to Physician-Led, Hospital-Based RR-TB Treatment: A Cluster Randomized, Non-Inferiority Trial

In South Africa (SA), Mycobacterium tuberculosis (TB) is managed within primary care clinics (PCCs), where
nurses treat drug-susceptible TB and TB/HIV coinfection with treatment outcomes rivaling the best in the world.
A PCC management strategy offers a more convenient, patient-centered, differentiated model of care that
integrates TB and HIV treatment within the same setting. A diagnosis of rifampicin-resistant TB (RR-TB),
however, upends this model, requiring referral to a hospital-based, physician-led outpatient treatment center.
Hospital-based, physician-led models add significant patient-associated costs, with estimates suggesting 81% of
RR-TB patients experience catastrophic costs even in a decentralized outpatient model. There is hope, however,
to move RR-TB care into PCCs and in many settings this involves nurse-led management. The BringBPaL2Me
Trial is a multi-principal investigator, multi-site, cluster randomized, non-inferiority trial (CR-NIT), to compare
nurse-led RR-TB treatment in PCCs to standard of care physician-led RR-TB treatment at district hospitals in
the provinces of KwaZulu-Natal (KZN), Gauteng (GP) and Eastern Cape (EC), SA. Clusters include 10 PCCs
affiliated with 5 decentralized outpatient programs at RR-TB district hospitals (n=50 clusters). We estimate the
need to screen 3,800 RR-TB positive patients to enroll 2,944, or 64 RR-TB participants per PCC cluster. We
estimate 60-70% will be HIV co-infected. The interclass correlation is 0.024 based on our prior CRT enrolling
3,000 patients in KZN and EC. The non-inferiority margin is set at 5% with the assumption of 90% treatment
success in the physician-led arm. Treatment will include either a 6-month RR-TB regimen (i.e., bedaquiline,
pretomanid, linezolid and moxifloxacin, or BPaLM) or fluroquinolone-resistant TB (i.e., BPaL) regimen. The
BringBPaL2Me primary aim is to conduct a 5-year, analyst and clinical safety review committee blinded, multi-
site, CR-NIT to evaluate 1) treatment outcome; 2) safety; and 3) patient associated catastrophic costs with the
following hypotheses: 1) Outpatient nurse-led treatment in PCCs will be non-inferior to outpatient physician-led
treatment at hospital-based outpatient sites among RR-TB patients, regardless of HIV co-infection, as
determined by a successful treatment outcome [H1]; 2) The proportion of severe adverse events (SAEs) identified
will not significantly differ by blinded, independent review [H2]; 3) Patient associated catastrophic costs (i.e.,
costs 20% or more of household income) will be lower in nurse-led treatment [H3]. Our secondary aims include:
1) time to event analysis for a) RR-TB treatment initiation; b) smear/culture conversion; and, as applicable, c)
HIV treatment initiation; d) HIV viral suppression; and e) AE and SAE symptom resolution; 2) characterization
of provider adherence to guidelines for: a) dosing requirements; b) RR-TB dosing changes based on AE and SAE
events; and c) AE and SAE adjuvant medication management strategy; 3) programmatic cost-effectiveness
evaluation of PCC management. Bring BPaL2Me has strong multi-PI collaborations with support from the
national/provincial department of health teams and a rigorous design to evaluate effectiveness, safety and costs.

Public health relevance
Tuberculosis (TB) is a leading infectious disease killer among people with and without HIV in South Africa where antibiotic resistant forms of the infection are a significant public health concern. Newer treatment regimens for antibiotic resistant TB are shorter, better tolerated and have greatly improved treatment outcomes, yet access to these regimens is limited to physician-led, hospital-based programs. The BringBPaL2Me Trial will test whether it is safe and effective to offer such treatment in a primary care clinic using a nurse-led treatment model, as such, this trial has the potential to improve access to care and significantly reduce patient and health system costs.